Developmental Research Project Program

Developmental Research Program (DRPP) - Project Summary
The Development Research Project Program provides an array of support programs to develop
competitive biomedical research faculty in Kentucky’s colleges and universities. The primary
assumption underlying this program is that each Kentucky institution needs a critical mass of
independent biomedical research faculty in order to provide the highest quality biomedical
research training to undergraduate students. Furthermore, Kentucky research faculty must be
provided with the infrastructure to succeed in their research careers in order to provide first-rate
research experiences to undergraduate students, which will inspire them to join the biomedical
workforce. With the overarching goal of increasing biomedical research capacity in Kentucky, the
Developmental Research Project Program aims to address the existing low numbers of
independent research faculty, and existing deficits in infrastructure, by enhancing faculty
recruitment, promoting the research and career development of junior faculty, and building a
sustainable research network. Based upon our past successes, we will focus our efforts on
institutions eligible for NIH R15 funding. These institutions are primarily undergraduate institutions
(PUIs), so this concentration provides the greatest benefit to undergraduate students. At these
institutions, we focus our efforts on developing faculty to increase success rates in obtaining R15
funding. In this way, we have been successful in increasing the numbers of independent research
faculty, and building a sustainable research network.